Immunologic Monitoring (IM)

PROJECT SUMMARY/ABSTRACT (IMMUNE MONITORING)
The Immune Monitoring Shared Resource (IM-SR) was established by the University of Michigan (U-M) Rogel
Cancer Center (Rogel) in 1999 and has been continuously funded by the Cancer Center Support Grant
(CCSG) since 2001. The goal of IM-SR is to foster, facilitate, and support basic, translational, clinical, and
population science researchers who seek to enhance understanding of cancer immune response and
therapies. IM-SR benefits from the leadership of Co-Directors who have diverse yet complimentary expertise.
Together, they provide leading-edge scientific knowledge and front-line researcher perspectives as they guide
SR services, equipment, and technology. Users pursue basic science and translational research, with the goal
of advancing knowledge of the role of the immune and inflammatory responses in cancer initiation,
progression, and metastasis, as well as therapeutic efficacy and resistance.